Systematic Genetic Analysis of C. albicans CNS Infection

PROJECT SUMMARY
The central nervous system (CNS) is an important target organ for nearly every major human fungal
pathogen including Cryptococcus, Coccidioides, Candida, Aspergillus, Histoplasma and others. In almost all
examples, the fungus either colonizes or infects one organ system and then disseminates to the CNS. The
most common initial site of infection is the lung as exemplified by the pathogenesis of Cryptococcus,
Histoplasma, Coccidioides, and Aspergillus while Candida albicans is unique in that it is a commensal of the
human GI tract that infects in the brain during invasive disease. Premature infants have long been recognized
as the patient cohort most at-risk for C. albicans CNS disease, although recently it has been recognized that
adults with mutations in the CARD9 innate immune pathway are also at high risk. Importantly, C. albicans
meningoencephalitis contributes to the fact that, among infants who survive sepsis, those infected with C.
albicans have much poorer neurodevelopmental outcomes than infants infected with bacteria. Thus, CNS
disease is a clinically important sequelae of candidiasis. However, we know very little about the mechanisms
that underlie the ability of C. albicans to infect the CNS. To address this gap in knowledge, we propose to
utilize a new model of C. albicans CNS infection to screen collections of transcription factor (TF) and protein
kinase (PK) mutants to identify key regulators of C. albicans neurotropism. We discovered that mice lacking
the IL-1 receptor (IL1-R) develop dramatically increased brain burden during disseminated candidiasis relative
to congenic WT mice. The increased CNS fungal burden in il1r-/- mice provides sufficiently robust dynamic
range to allow the identification of C. albicans mutants with decreased CNS infectivity whereas standard WT
mouse strains are only transiently infected by C. albicans at relatively low fungal burden. We, therefore,
propose to use this novel model to perform a genetic screen to identify TFs and PKs that are required for C.
albicans CNS infectivity (Aim 1). We will generate competitive fitness profiles of barcoded pools of TF mutants
isolated from mouse brain tissue after both intravenous (IV) and intracranial (IC) inoculation routes. In Aim 2,
we will characterize the effects of a focused set of TF and PK mutants by: 1) analyzing their interactions with
on brain endothelial cells; 2) determining their effect on the transcription of virulence and environmentally
responsive genes in vivo during CNS infection; and 3) determining their genetic interaction profiles with the
other TFs and PKs. These experiments will provide the first characterization of the genetic and transcriptional
requirements for C. albicans CNS infection and will set the stage for future, detailed mechanistic studies of C.
albicans neurotropism.

Public health relevance
PROJECT NARRATIVE In premature infants and people with specific alterations to immune function, Candida albicans causes infections of the central nervous system (CNS) leading to death or devastating neurodevelopment deficits in surviving patients. Very little is known about the mechanisms by which C. albicans causes CNS disease. Our project aims to use a novel mouse model of C. albicans CNS infection to characterize the transcription factors required to cause CNS disease. This exploratory grant will set the stage for more in-depth studies with the ultimate goal of identifying potential strategies to prevent or better treat these infections.